Stanford Integrated Cardiovascular/Pulmonary Residency Research Training Program

PROJECT SUMMARY
Stanford University School of Medicine is a site of unparalleled excellence in biomedical research and is an
innovative leader in the fields of cardiovascular and pulmonary medicine. This renewal of the Stanford
Integrated Cardiovascular/Pulmonary Residency Research Training Program provides research
opportunities for talented individuals engaged in the residency stage of their medical training. The program draws
resident investigators from the Stanford residency programs in Internal Medicine, Pediatrics, Cardiothoracic
Surgery, Vascular Surgery, and Radiology, and place them in basic, translational, and clinical research
laboratories affiliated with the Stanford Cardiovascular Institute (CVI) for a mentored research experience
lasting 1-2 years. Upon completion of their clinical training, successful resident-investigators are eligible for K38
funding to support continued research efforts. For this renewal of our program, we will build upon the success of
the previous four years in supporting residents across multi-disciplines. Research mentors for our StARR
program are members of the Stanford CVI, which offers a unique platform to train the next generation and
translational scientists. Major research programs within the CVI span Cardiac, Vascular, and Pulmonary disease
categories, incorporating the disciplines of Genomics, Proteomics and Bioinformatics; Cellular and
Molecular Biology; Imaging; Bioengineering; and Population Science. CVI scientists share a common
interest in the mechanisms underlying cardiovascular and pulmonary medicine, and work together towards
creating novel therapeutic, regenerative, and preventative approaches to cardiovascular and pulmonary
diseases. Furthermore, the CVI offers multifaceted educational and career development programs that enhance
the experience of R38 StARR trainees and prepare them to launch successful academic careers as clinician-
scientists. Our renewal of the Stanford Integrated Cardiovascular/Pulmonary Residency Research Training
Program will foster the career development and research training of resident-investigators who will continue on
to careers as clinician-scientists in the fields of cardiovascular and pulmonary medicine.

Public health relevance
PROJECT NARRATIVE Cardiovascular and pulmonary diseases are the leading causes of death in the United States, claiming over a million lives each year and exerting an undue financial toll. There is an ongoing unmet need to develop a cohort of clinician scientists who can combine their rigorous clinical training with research initiatives to pioneer new approaches and innovations for cardiovascular and pulmonary disease therapy and prevention strategies. The renewal of the R38 StARR grant will continue to provide mentored training opportunities for medical residents in laboratories at Stanford University School of Medicine focused on Cardiovascular and Pulmonary Health, promoting their pursuit of the clinician-scientist career path.